Didactic Interactions Component

Project Summary—Promoting Center Expertise
Creating awareness of and engagement with the Center for Smart use of Technologies for Assessment of Real-
world Outcomes (C-STAR) will be an essential undertaking to ensure Center success. The challenge is
augmented by the need to connect to a small (< 5,000) and diverse target audience of basic and clinical
researchers stretching across multiple scientific, technical, and diagnostic domains. Additionally, continued
engagement with the target audience will be necessary to promote, disseminate, and amplify C-STAR outcomes.
To achieve our goal, we propose two specific aims: (1) To create awareness and consideration such that our
target audiences will want to “Connect” and begin active engagement with C-STAR. (2) To “Share” (e.g.,
disseminate) outcomes from C-STAR as well as provide access to research resources. We intend to achieve
these aims through a variety of methods—all market tested for efficiency and effectiveness over several years
by the Shirley Ryan AbilityLab marketing team. We will achieve Aim 1 by tapping into a diverse set of marketing
channels to ensure maximal reach and impact with our targets. It is critical that we not over-rely on any one
strategy but instead recognize that our target audiences engage across many marketing channels and thus we
must seek them out in those channels. Additionally, multiple exposures to our messaging in different formats will
help break through ambient clutter to drive awareness and consideration of C-STAR. Accordingly, our primary
marketing vehicles for Aim 1 will include such tactics as: cross-promoting C-STAR on our proprietary
Rehabilitation Measures Database website, conference exhibits, targeted advertising on social media, monthly
emails to prospects and those who are already engaged, and advertising through associations and universities.
To achieve Aim 2, we will utilize many of the strategies and tactics summarized above. In addition, we will build
and promote C-STAR's web portal—which will be designed to house outcomes from pilot studies, collaborations,
data sets, research manuals and reference articles—and plan and promote annual symposia that focused on
latest findings and outcomes.